The Building Research Independence by Developing Goals and Hands-on Experiences (BRIDGE) Program

PROJECT SUMMARY
When entering college, similar numbers of underrepresented minority (URM) students plan to major in STEM
fields as non-Hispanic white students. However, pipeline leakage reduces the number of URM students entering
STEM careers following graduation. One way to address this pipeline leakage is via undergraduate research
experience, which improves retention of students in STEM disciplines and the pursuit of advanced degrees.
Given the benefits of undergraduate research experience, Temple University has programs that encourage
undergraduate participation in neuroscience and psychology research, such as an NIH ENDURE grant and
Independent Study credit options. However, these programs either require or prioritize students who can give a
2-year commitment. Thus, transfer students, students who are late to find their passion for research, and
students who do not know about or feel comfortable asking about research opportunities until later in training,
often miss out on the participating in undergraduate research. Additionally, Independent Study, which provides
most research opportunities to undergraduates, is compensated via course credit, which can be an impediment
for students who need to earn money to support their education (a large portion of Temple undergraduates). We
started the Building Research Independence by Developing Goals and Hands-on Experiences (BRIDGE)
program in 2021 to address these barriers. BRIDGE targets neuroscience and psychology majors who meet the
NIH guidelines for underrepresented populations and have not had the opportunity for research experience prior
to their last (typically senior) year of college. BRIDGE provides scholars with paid summer research experience,
individualized mentoring, and networking and professional development opportunities. This R25 grant would
increase the support for the existing BRIDGE program, allowing students to work full time over the summer and
providing travel funds, options that are not currently available. This funding would also support a near-peer
mentoring program where doctoral students would mentor BRIDGE scholars. Near-peer mentoring amplifies the
participation of underrepresented students in science by positively affecting both mentees and mentors. Overall,
the BRIDGE program will demystify the research process and provide more students underrepresented in
science with tools to pursue biomedical careers.

Public health relevance
PROJECT NARRATIVE Undergraduate research experience improves retention of underrepresented students in STEM disciplines, but most research programs target undergraduates in their sophomore year, leaving a group of students who do not want research experiences until later in their training with few options. The Building Research Independence by Developing Goals and Hands-on Experiences (BRIDGE) program addresses this barrier by providing paid summer research experience, professional development opportunities, and mentoring to underrepresented students with no prior research experience going into their senior year. Importantly, the BRIDGE program will increase diversity in biomedical fields.